ANALYSES OF DATA FROM THE COLLABORATIVE PERINATAL PROJECT

The Collaborative Perinatal Project (CPP) represents a rich data set for the investigation of a variety of topics related to maternal and child health. Currently active areas of investigation include the descriptive epidemiology of congenital cataract, the association between maternal smoking and childhood cancer, and the association between elevated maternal serum levels of alpha fetoprotein at 14-20 weeks and subsequent stillbirth.